Elucidating the barriers and facilitators to widespread implementation of preconception genetic carrier screening

Screening of prospective parents to determine if their offspring are at risk for potentially devastating heritable
conditions with genetic carrier screening has resulted in measurable decreases in the number of newborns
affected by severe recessive disorders. Although professional societies such as the American College of
Obstetricians and Gynecologists and the American College of Medical Genetics advocate for genetic carrier
screening to be done prior to pregnancy (preconception), access to preconception genetic carrier screening
remains low and inequitable. This is because implementation of carrier screening in a diverse national
population is complicated and requires 1) understanding the barriers and facilitators of screening at all levels of
healthcare delivery, 2) recognizing patient preferences for test delivery, and 3) clarifying potential personal
health implications of carrier screening. This award will be used to address these three gaps in our
understanding of preconception genetic carrier screening. First, I will interview key informants with experience
at all levels of healthcare delivery about their perceptions of the barriers and facilitators to implementing
preconception carrier screening programs. Second, I will systematically elicit patient preferences about how
genetic carrier screening should be delivered using a discrete choice experiment. The discrete choice
experiment will consist of a web-based survey in which different attributes of how preconception carrier
screening is offered are varied and prospective patients must choose their preferred screening method. This
survey will be administered to two separate cohorts of women of reproductive age to encourage a diversity of
responses. Finally, I will use phenome-wide association study methods to investigate whether carriers of
autosomal recessive disease are at high risk of other adult diseases. I will focus on CFTR, HBB, and GBA,
which are implicated in the autosomal recessive disorders cystic fibrosis, sickle cell anemia, and Gaucher
disease, respectively. This study will generate key pilot data that will be used to design testable implementation
strategies to enable widespread use of preconception carrier screening. These strategies and their impact on
patient care will subsequently be tested in a randomized clinical trial through a future grant application.

Public health relevance
Preconception carrier screening is a proven, evidence-based genetic screening approach that has the potential to prevent pregnancies affected by severe recessive genetic conditions, but widespread and equitable implementation of this testing has not been achieved. The proposed research program will evaluate diverse stakeholders’ preferences for how preconception carrier screening could be performed and the personal health implications of carrier screening. This program has the potential to inform implementation efforts to expand access to preconception carrier screening among diverse populations.